Cyclic Orynotides for Systemic MDR Candidiasis

This Fast Track SBIR grant proposal seeks to develop a new class of macrocylic peptide drugs for treatment of
systemic candidiasis, an increasingly frequent cause of serious and often fatal infections in hospitalized and
immunosuppressed patients. Mortality rates associated with these infections have risen sharply due to the
emergence of multidrug resistant (MDR) strains of C. albicans and other Candida spp. Currently, there are but
three classes of antifungal drugs available for treatment of invasive fungal diseases (polyenes, azoles, and
echinocandins), and it has been nearly two decades since the last new class of antifungals (echinocandins) was
approved. MDR isolates of Candida spp. that are resistant to all azoles and echinocandins are increasingly
common, highlighting the urgent need for new antifungal therapeutics. This project seeks to develop a new class
of proprietary antifungal peptides, OrynotidesTM, the design of which was bioinspired by θ-defensins, cyclic host-
defense peptides expressed in Old World monkeys but not humans. A lead series of 35 Orynotides, down-
selected from a larger proprietary library, is composed of macrocyclic peptides that are potently fungicidal against
clinical isolates of MDR C. albicans and other pathogenic Candida spp., including C. auris a highly virulent
globally emerging pathogen. Each of the Orynotide candidates has been prequalified as being fungicidal, highly
stable in biological matrices, stable to proteases in fungal lysates, non-toxic to mice, and readily manufacturable.
Among the prequalified Orynotides are compounds that markedly enhance survival in two models of systemic
candidiasis including infections caused by caspofungin resistant C. albicans and MDR C. auris. Based on these
findings, we propose in Phase 1 of the project to identify at least three peptides (from the prequalified panel of
35 Orynotides) that are equal or superior to a reference Orynotide that is effective in murine C. albicans
candidiasis. Comparative efficacy metrics will include enhanced survival, reduction of fungal burden, and
maintenance of body weight. Achievement of this Phase 1 milestone would trigger Phase 2 studies. The first of
two Phase 2 Aims will identify a lead Orynotide, from 3-5 lead finalists, for preclinical development based on
therapeutic efficacy, safety, and exposure-response analyses in immunocompetent and neutropenic mice.
Phase 2 studies will then focus on IND enabling GLP toxicology studies of the lead Orynotide, with the goal being
to file an IND by the end of the third year of Phase 2. Completion of this objective will position the applicant and
its partners to introduce a new class of antifungal drugs for treatment of systemic candidiasis. This would
represent the first new antifungal class to be introduced for human mycoses in nearly two decades.

Public health relevance
Project Narrative Invasive fungal diseases represent a growing threat to human health worldwide, exacerbated by the increasing incidence of multi-drug resistance among fungal pathogens. Currently there are but three classes of antifungal drugs that may be used to treat these infections, the last class of which was introduced nearly two decades ago. The proposed research seeks to develop a new class of antifungal drugs to address this unmet clinical need.